The roles of the Pseudomonas aeruginosa Prc/AlgO protease - Resubmission - 1

PROJECT SUMMARY
The bacterial pathogen Pseudomonas aeruginosa causes life-threatening human illnesses, including acute
pneumonia, long-term lung colonization in cystic fibrosis patients, and severe wound infections. Most infections
are associated with compromised host defenses and this, together with the common environmental occurrence
of P. aeruginosa, makes it a leading cause of hospital-acquired infections. Treatment of P. aeruginosa disease
is often challenging, in part because of its intrinsic resistance to antibiotics as well as occasional outbreaks of
multi-drug-resistant strains. Therefore, there is an urgent need to characterize new targets for therapeutic
attack. The P. aeruginosa cell envelope contains a C-terminal processing protease (CTP) named CtpA, which
is essential for acute infection. CtpA has adopted a similar role to that of the only CTP found in Escherichia
coli, Prc, even though CtpA and Prc are quite different from each other. Both CtpA in P. aeruginosa, and Prc in
E. coli, degrade enzymes that remodel the bacterial cell wall. This is intriguing because whereas many bacteria
like E. coli have only one CTP, P. aeruginosa has two, and the second one is named Prc because it is very
similar to E. coli Prc. This raises the new question for this exploratory/developmental proposal: if CtpA
achieves the role played by Prc in E. coli, then what does Prc do in Pa? Prc has been proposed to cleave the
negative regulatory protein MucA, triggering extracellular polysaccharide production and a phenotype
associated with a poor prognosis in cystic fibrosis patients. However, neither MucA or any other P. aeruginosa
protein has been demonstrated to be a Prc substrate. From our preliminary data, we are proposing an exciting
new model for the differential control of at least one PG cross-link hydrolase by both Prc and CtpA. Together
with our other observations suggesting that Prc affects the cell wall, this supports our central hypothesis, which
is that Prc cleaves important proteins involved in cell wall metabolism, and that this might have an indirect
impact on the cleavage of the anti-sigma factor MucA. To test this hypothesis, we will: (1) Determine if Prc and
CtpA play different roles in degrading common substrates and (2) Establish how Prc affects alginate regulation
and the mucoid conversion phenotype. This work will impact our understanding of fundamental, conserved
processes important to almost all bacteria. It will also provide the first clear insight into exactly what Prc does in
Pa, and the mechanism(s) by which it affects alginate biosynthesis, mucoid conversion, and cell wall features
that impact human health. Understanding these mechanisms might ultimately help the development of new
therapeutic strategies against this widespread, dangerous and very costly human pathogen.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to human health because it focuses on Pseudomonas aeruginosa, which causes serious human infections, particularly in hospitalized patients, those with weakened immune systems, and individuals suffering from cystic fibrosis. The work will characterize the role of a P. aeruginosa enzyme that has been implicated in promoting chronic infections, and affecting one of the most important drug targets in many bacteria, the cell wall. In the long-term, this enzyme and its substrates could be therapeutic targets for the treatment of infections by this devastating pathogen.